FUSION GLYCOPROTEIN OF RESPIRATORY SYNCYTIAL VIRUS

We have used 18 neutralizing monoclonal antibodies (MAbs) specific for the respiratory syncytial virus (RSV) fusion (F) glycoprotein to construct operational, topologic, and functional epitope maps of the F glycoprotein. The MAbs define 16 neutralization epitopes which are organized into three non-overlapping antigenic sites (A, B, and C) and one bridge site (AB). Neutralization and fusion- inhibition tests of the MAbs indicated that antigenic sites A, AB, and C correspond to functional domains of the F protein involved in syncytium-formation, whereas antigenic site B does not participate directly in the fusion process. This conclusion is reinforced by two additional observations. First, MAb-resistant variants selected with site B MAbs produce normal plaques, whereas those selected with MAbs binding epitopes in sites A and B produce pinpoint plaques. Second, epitopes in antigenic sites, A, AB, and C (which correspond to functional domains) were less variable among RSV clinical isolates than were epitopes in antigenic site B. Sequence analysis of the F genes of antibody-resistant mutants will allow us to identify amino acid residues which are responsible for binding neutralizing antibodies and which participate in syncytium- formation.